Predicting Speech Recognition in Adults Receiving Cochlear Implants

Project Summary/Abstract:
Acquired hearing loss is becoming increasingly common, especially with the growth of the aging population.
For many individuals, hearing loss is severe enough to warrant cochlear implantation. While many adults
with cochlear implants (CIs) understand speech well through their devices, enormous unexplained variability
exists in speech recognition outcomes, as well as in the trajectory of speech recognition improvement (i.e.,
perceptual learning) after implantation. Unfortunately, because of this unexplained variability, clinicians are
unable to predict how an individual will perform with a CI, to explain why someone has poor speech
recognition with a CI, or to design appropriate rehabilitation strategies to help an individual with poor
performance. Currently, only half of this outcome variability can be explained by traditional clinical measures.
Recent studies have suggested that individual differences in speech recognition among CI users reflect
variability in more basic sensory (“bottom-up”) and cognitive-linguistic (“top-down”) factors. These factors
should explain additional variability in CI outcomes, and a comprehensive integrative model incorporating
traditional clinical measures along with bottom-up and top-down factors is needed. The overall objective of
the proposed project is to fill the gap in knowledge regarding the sources of unexplained variability in CI
speech recognition outcomes and perceptual learning. Aim 1 will determine the degree to which pre-
operative measures of bottom-up sensory functions and top-down cognitive-linguistic processes predict CI
speech recognition outcomes. Aim 2 will investigate the degree to which additional objective bottom-up
sensory processes, and especially their interactions with top-down factors, explain sentence recognition. Aim
3 will investigate the trajectories of perceptual learning in speech recognition that occur during the first two
years of CI use. The findings from this research project will have important theoretical and clinical
implications by comprehensively delineating the contributions and interactions of bottom-up and top-down
factors as they relate to variability in recognition of speech, as well as helping clinicians to better predict
pre-operatively and understand post-operatively the outcomes and time course of perceptual learning that
occurs after implantation.

Public health relevance
Project Narrative: With the growth of the United States’ aging population, acquired deafness is becoming increasingly common, and many individuals suffer hearing loss severe enough to warrant cochlear implantation. Enormous speech recognition outcome variability exists in adult cochlear implant (CI) users, which is only partly explained by clinical measures, and this unexplained variability impedes our ability to predict postoperative outcomes, identify sources of poor outcomes, and tailor rehabilitation protocols for individuals. This project will determine how a comprehensive approach including “bottom-up” sensory and “top-down” cognitive-linguistic factors predicts CI outcomes after implantation.